Innovating a Personalized Reinforcement Interface to Motivate Engagement (PRIME) Among Care Partners for People Living with Alzheimer's Disease and Related Dementia in their Communities

PROJECT SUMMARY / ABSTRACT
By 2050 in the U.S., an estimated 13 million individuals will be impacted by ADRD. The rise in Alzheimer’s
disease and related dementia (ADRD) cases presents a significant challenge for both people living with
Alzheimer’s and related diseases (PLWAD) and their care partners. Even now, over 16 million care partners of
PLWAD (generally unpaid family members) – and the healthcare system itself – face considerable pressure and
strain to support PLWAD, and that pressure will only grow in the future. However, a notable gap exists in tailored
solutions for care partner's needs. Immediate actions are needed to develop a comprehensive support
intervention to improve care partner self-efficacy, which can lead to relieving the burdens of caregiving and
ensuring their well-being.
For this Fast Track SBIR project, we propose the proposed AWC-PRIME (Personalized Reinforcement Interface
to Motivate Engagement) product builds upon our existing Adult Wellbeing Checkup (AWC), a platform that
facilitates wellbeing assessments, referrals, and personalized recommendation plans for older adults, including
care partners. AWC-PRIME extends and complements our initial AWC platform for older adults by providing a
dynamic companion app that validates and supports behavioral changes for CPs. The app ensures that CPs are
not only well-informed but also continuously motivated and supported in their self-care and stress-management
efforts. AWC-PRIME will 1) support CPs in identifying their level of needs, 2) encourage SMART goal setting
through MI, 3) develop personalized, theoretically-supported self-management plans, 4) support goal attainment
through MI and tailored coaching, 5) scale AI-powered coaching, and 6) provide pathways to peer support online
or through local community-based organizations for additional support and reinforcement. Innovations include
building high degrees of interactivity digitally (e.g., via chatbots and two-way messaging) and seamlessly
interweaving multiple modalities to increase engagement. Our Fast Track application’s Phase 1 with Aim 1 to
co-create the AWC-PRIME prototype and Aim 2 to assess feasibility of the AWC-PRIME prototype. For Phase
2, we will revise and finalize AWC-PRIME in Aim 3 and conduct an RCT in Aim 4.
The short-term impact of the project through Phase I will involve the co-creating and initial testing of the AWC-
PRIME prototype. Additionally, the feasibility testing of the AWC-PRIME prototype and Phase I findings will
provide the foundation for further refinement in Phase II. Ultimately, we aim to provide a tool for care partners to
receive personalized support through motivational interviewing techniques, while taking action on their SMART
goals, which care partners find both easy-to-use and effective in improving self-efficacy.

Public health relevance
PROJECT NARRATIVE The Adult Wellbeing CheckUp-Personalized Reinforcement Interface to Motivate Engagement (AWC-PRIME) is an extension of the Adult Wellbeing Checkup (AWC) platform. Unlike the web-based AWC, AWC-PRIME is a mobile app designed to enhance interactive engagement among care partners of people living with Alzheimer’s and related dementia, focusing on improved self-care and stress management. While AWC-PRIME’s targeted end-users are care partners seeking support for implementing behavioral changes to improve their well-being, its customer base would include healthcare providers, government entities, and other organizations addressing care partner burden.